Hybridized structure- and ligand- based drug discovery approaches targeting ASCT2, an amino acid transporter critical for upregulated cell proliferation in numerous cancer types

Hybridized structure- and ligand- based drug discovery approaches targeting ASCT2, an amino acid
transporter critical for upregulated cell proliferation in numerous cancer types
This proposal outlines the protocols and techniques I will be using to optimize drug discovery
of ASCT2, a promising target for anti-cancer therapeutics. ASCT2 plays a key role in increasing the
glutamine influx for tumor cells to maintain such high metabolic rates required for rapid proliferation.
The first structures of ASCT2 were recently determined experimentally, making this a newly viable
target for structure-based studies ASCT2 was only recently discovered to play a critical role in cancer
cell metabolism and little medicinal chemistry efforts have been focused on ASCT2 antagonist
development allowing immense potential for breaking into new compound scaffolds for further testing.
Currently, there have not been any ASCT2 drug campaigns that incorporate computational drug
discovery methods and this proposal outlines the first studies dedicated to this.
Many institutions and pharmaceutical companies have implemented computational strategies
into drug discovery pipelines as a means to produce viable drug candidates in a more cost-efficient
and timely manner. Depending on the target of interest, researchers focus more intently on either
ligand-based (LB) or structure-based (SB) methods, but rarely are these two methods hybridized in a
sophisticated fashion. By utilizing strategies of both LB- and SB- computational drug discovery, I
intend to merge the advantages of both methodologies as a means to sample and filter large
chemical space more efficiently. Our lab has active development in two computational chemistry
software suites: Rosetta primarily focuses on SB methods whereas the Biology and Chemistry Library
(BCL) contains advanced cheminformatics toolsets for LB methods. The focus of my project will be to
integrate the RosettaDrugDesign code to allow a more extensive, yet efficient sampling of chemical
space using ligand-based techniques. We intend to incorporate these more advanced LB techniques
available in the BCL, including multi-tasking artificial neural networks for Quantitative Structure-
Activity Relationship predictions, to filter compounds during docking simulations within the
RosettaDrugDesign. By bringing together the structure prediction abilities of Rosetta and small-
molecule tools of BCL, we anticipate exceptional advances in our abilities to efficiently design drugs
for ASCT2.

Public health relevance
Project Narrative The upregulated influx of amino acids is critical to maintain an altered metabolic state for rapidly proliferating cells such as those found in tumors, making transporters such as ASCT2 a promising target for cancer therapeutics. Computational-based drug discovery methods have not been heavily utilized for ASCT2 due to lack of an experimentally determined structure; however with the recently solved structure, these methods are now possible and highly favorable for guiding medicinal chemistry efforts. This proposal outlines the plans for hybridized structure- and ligand-based approaches for computational drug discovery of ASCT2 antagonists and the experimental validation obtained utilizing in silico methods.